Neuronal mechanisms of learning and utilizing abstract representations

Project summary
Using memories of past experiences to guide behavior in novel situations is an important function of the brain.
Doing so efficiently is thought to rely on the process of abstraction, which extracts and summarizes relevant
aspects from prior experiences and thereby enables usage of the acquired knowledge to solve novel future
situations efficiently. Despite the importance of abstraction for human cognition, little is known about the
underlying mechanisms and their disruption by disease or injury. The long-term goal of this research is a
circuit-level understanding of abstraction to enable the development of new treatments for the devastating
effects of cognitive disorders in which abstraction fails. Our experiments utilize the rare opportunity to record
in-vivo from human single neurons simultaneously in multiple brain areas in patients undergoing treatment for
drug resistant epilepsy. The overall objectives of this project are to build a multi-institutional (Cedars-
Sinai/Caltech, UC Davis, Barrow Neurological Institute, Columbia University), integrated, and multi-disciplinary
team to use human single neuron recordings to examine the neural substrate of abstraction. We will
investigate three overarching hypotheses on the neural substrate of abstraction. First, we will determine the
dynamics of learning abstract representations (Aim 1). Second, we will decipher how abstract representations
facilitate generalization (Aim 2). Third, we will decipher how abstract representations facilitate analogical
reasoning (Aim 3). The expected outcomes of this work are a characterization of how abstract neural
representations are formed, how they enable generalization to novel stimuli and tasks, and how they enable
analogical reasoning. This work is significant because we test circuit-based hypotheses by simultaneously
recording single-neurons from multiple frontal cortical and subcortical temporal lobe areas in humans who are
forming and using abstract representations. The proposed work is unusually innovative because we combine
single-neuron recordings in in behaving humans with new tools to examine neural geometries and their
relationship to behavior, develop new methods for the characterization of the format of neural information, test
the major theory that it is abstract representations, and their property of compositionality, that enable out-of-
distribution generalization, and we test the theory that abstract representations are build by disentangling
existing representations much like learning occurs in machines. A second significant innovation is our team,
which combines the patient volume and expertise of several teams to maximally utilize the rare neurosurgical
opportunities available to study the human nervous system at single cell resolution. This innovative approach
permits us to investigate circuit-level mechanisms of human cognition that cannot be studied non-invasively in
humans nor in animal models. This integrated multi-disciplinary combination of physiology, behavior, and
modeling will contribute significantly to our understanding of the circuits and patterns of neural activity that give
rise to abstraction, which is a central goal of human neuroscience and the BRAIN initiative.

Public health relevance
Project Narrative Using memories of past experiences to guide behavior in novel situations is an important function of the brain that is thought to rely on the process of abstraction, but the underlying neural mechanisms remain poorly understood. The objective of this exploratory project is to assemble a multi-disciplinary and multi-site team to examine multiple initial hypotheses on the underlying neural substrate that can only be evaluated by observing and studying neurons in-vivo in humans enabled by rare neurosurgical opportunities. We will test three aspects of abstraction about which little is known: how abstract representations are learned, whether and how they support generalization to novel situations, and whether and how they support analogical reasoning.